Focused ultrasound for memory disorders

Summary/Abstract
Working memory (WM) is a core component of executive function. WM is impaired in conditions that affect
roughly 20M people in the US alone, including Alzheimer’s disease (5.8M), Parkinson’s disease (1.2M),
schizophrenia (1.5M), attention deficit hyperactivity disorder (6.1M) and autism spectrum disorders (7.3M).
Despite this, there are few non-addictive medical treatments that are effective in ameliorating working memory
deficits. Focused ultrasound (FUS) is an emerging noninvasive method of brain stimulation that has the ability
to reach deep brain structures. FUS has been used for direct neuromodulation and to open the blood-brain
barrier (BBB) for targeted drug delivery. The proposed experiments will test the effects of FUS
neuromodulation and drug delivery on working memory performance in awake, behaving nonhuman primates
(NHP) as a step toward developing novel therapies for dementia. The experiments will also address the
mechanism of action of FUS neuromodulation and BBB opening in cortico-striatal circuits using a suite of MRI
methods (BOLD, DTI, UTE, pcASL, and qBOLD). Finally, we will address the safety of FUS neuromodulation
and BBB opening in cortical and deep brain structures; this has not been done previously and establishing
safety in NHP is a critical step prior to a clinical trial. We have demonstrated that FUS can be used to improve
behavioral performance during decision making in NHP and now propose to evaluate FUS for improving WM.
Aim 1 will test the effects of FUS neuromodulation alone on working memory capacity and span in intact and
impaired NHP, and compare FUS to electrical deep brain stimulation. Aim 2 will test the effects of FUS-
mediated blood-brain barrier opening and drug delivery and on working memory. Aim 3 will investigate the
mechanism of FUS neuromodulation using noninvasive MRI. Broader Impact: This project will provide
preclinical safety and efficacy data for human neuromodulation studies focusing on cognitive deficits
associated with neurological and psychiatric disorders.

Public health relevance
Narrative The goal of this project is to test the effect on spatial working memory of focused ultrasound for noninvasive brain stimulation and targeted drug delivery directed to the dorsolateral prefrontal cortex and dorsal striatum. Focused ultrasound could provide a new research tool for establishing causal brain-behavior relationships, mapping neural circuits in healthy humans, and a novel method for introducing neuroactive drugs that do not cross the intact blood-brain barrier (BBB). Focused ultrasound therapy could become a non-surgical alternative to treat cognitive impairments in patients with neurological or psychiatric disorders who experience working memory deficits.